MFRPS Maintenance NYSAGM

Project Abstract:
The New York State Department of Agriculture and Markets has an extensive food safety and
inspection program which includes jurisdiction over manufactured foods facilities. The Division
of Food Safety and Inspection has been enrolled in FDA's Manufactured Foods Regulatory
Program Standards since 2008 and is currently in full implementation and full conformance of
2019 MFRPS standards.
The Standards provide State manufactured food programs with a quality management
framework, and a foundation for a nationally integrated food safety system. Funding by FDA to
FSI will enable the maintenance of our full implementation to the 2022 Standards, continue the
capabilities of our inspection staff, support training, provide necessary staff resources to
maintain the Standards, maintain systems for auditing, data capture, and reporting and further
information sharing. With the additional special project funding, the State would like to expand
our current independent course delivery trainings from FD190, to include FD202, FD249 and
FD254 by working with FDA’s Patricia Alcock and the FDA/ORA/OTED team.

Public health relevance
Project Narrative: The New York State Department of Agriculture and Markets has a comprehensive food safety and inspection program. Support from FDA has enabled the Division of Food Safety and Inspection (FSI) to reach full implementation and conformance with all ten of FDA’s 2019 Manufactured Foods Regulatory Program Standards (MFRPS), and expand the capability of inspection staff, support training, provide additional staff resources to support the Standards, and improve systems for auditing, data capture, and reporting. Conformance with the MFRPS has placed the Department in a better position to share inspection information and data with FDA and other States, which will improve our response to, and help to prevent the incidence of food borne illnesses and food recalls.